Project 2: A brief motivational interviewing intervention to promote healthy technology use and prevent mental health and behavior problems

PROJECT 2 SUMMARY
About a third of adolescents engage in online risk behaviors such as problematic internet use, which has been
robustly linked to depression and anxiety among adolescents in longitudinal, bidirectional studies. Technology
used for entertainment among tweens younger than 13 continues to increase, averaging 5.3 hours a day.
Additionally, online risk behaviors predict sleep disturbances, which are prospectively related to mental health
problems among adolescents. Adolescence is a critical developmental window for intervening and promoting
healthy technology use given the significant physical, social, and emotional changes during this period. Brief
motivational interviewing interventions have demonstrated effectiveness among adolescents, and they hold
promise for accelerating delivery of mental health interventions in school-based contexts. Thus, our overall
goal is to develop the TECH Check-up (TCU), an evidence-informed brief motivational interviewing intervention
to promote healthy technology use and improve mental health and behavior problems. The first phase of the
TCU will include an interview with an early adolescent, an adolescent and caregiver self-assessment, and
feedback. Informed by social cognitive theory, the second phase will include four online modules for youth to
strengthen their technology use-related self-efficacy and self-regulation. As we develop the TCU, we will
employ the Consolidated Framework for Implementation Research (CFIR) to address barriers and facilitators
of intervention content and delivery strategies. We will also leverage a collaborative, participatory approach
and engage with adolescents, caregivers, and school partners via the center’s advisory boards to ensure the
TCU is acceptable and feasible. The first aim is to qualitatively identify crucial technology use attitudes, beliefs,
and behaviors among adolescents ages 11-14, caregivers, and school staff, which are necessary to develop
the TCU. We will conduct 6 CFIR-informed focus groups with adolescents, caregivers, and school leadership
(N ~ 45). Using rapid analysis methods, qualitative feedback will be integrated into our second aim, which is to
develop and iteratively refine the TCU content and delivery, including its brief motivational interview and four
online modules. We will conduct user testing in two Plan-Do-Study-Act cycles with additional adolescents,
caregivers, and school leadership (N = 12). The third aim is to identify the feasibility, acceptability, and initial
efficacy of the TECH Check-Up in a pilot randomized trial (N = 120) with 60 adolescents randomly assigned to
the intervention group, and 60 to a wait-list control group. We will assess the feasibility and acceptability of the
TCU and evaluate the initial efficacy of the TCU on healthy technology use, as well as youth mental health
(i.e., depression and anxiety) and behavior problems (i.e., sleep disturbances). This study addresses a public
health risk by developing an intervention to promote healthy technology use and self-regulation as protective
factors among adolescents, thereby reducing youth risk for mental health problems and behavioral concerns.